Inhibition of Neointimal Hyperplasia by Zinc-Based Biodegradable Arterial Devices

This document is not required for the NHLBI Research Supplement Application.

Public health relevance
This document is not required for the NHLBI Research Supplement Application.